Comparative Functional Genomics INBRE in Maine

OVERALL PROJECT SUMMARY
The Maine INBRE (ME-INBRE) is a statewide Network of 13 public and private institutions led by the MDI
Biological Laboratory (MDIBL). The Network is composed of two research institutes (MDIBL and The Jackson
Laboratory), one graduate degree granting university (The University of Maine), eight undergraduate colleges
and universities (Bates, Bowdoin, and Colby Colleges, College of the Atlantic, UMaine Honors College,
UMaine Farmington, UMaine Machias, and UMaine Presque Isle), one community college (Southern Maine
Community College), and one outreach university (UMaine Fort Kent), all of whom have confirmed their
commitment through letters and Memoranda of Understanding. First generation and non-traditional students
represent a substantial percentage of those attending ME-INBRE's academic institutions; the range is 16-63%
for public and 9-22% for private institutions. ME-INBRE's scientific focus on comparative functional genomics
fosters collaboration between scientists and students from multiple disciplines and institutions using
bioinformatics as a collaborative platform. Drs. James Coffman and Dustin Updike are Principal Investigator
and Program Coordinator, respectively. Their faculty mentoring, scientific leadership and administrative
activities will be supported and complemented by a highly qualified team of administrators and Core Directors,
a Steering Committee, and an External Advisory Committee. The Developmental Research Project Program
will foster the research and career development of exceptional faculty. Competitively selected project leaders
will include INBRE Investigators, who will devote 50% effort to a Research Project, and Research Training
Faculty from primarily undergraduate institutions (PUI), who will devote 15- 25% effort to a Pilot Project that
provides research opportunities for students on site at their PUI. Research training will be offered to
undergraduate and graduate students through programs designed to meet the diverse needs of our Network.
We anticipate that at minimum 1,000 individual research and research training experiences will be provided to
undergraduate and graduate students during the five-year grant period. The Bioinformatics Core will provide
comprehensive consulting in data management, computational infrastructure, rigor and reproducibility, and
analysis, as well as bioinformatics training through workshops, courses, and mentored research experiences.
The Research Training and Resources Core will coordinate management of core facility resources with
INBRE-funded research and research training programs. Collaborations with Maine COBREs and regional
IDeA programs will leverage resources, increase diversity, and engage students and faculty in basic,
translational, and clinical research opportunities that will complement and extend ME-INBRE's programs. The
Administrative Core will manage and coordinate all activities, and will implement formative and summative
evaluation of ME-INBRE programs and activities to guide efforts at maximizing their effectiveness.

Public health relevance
PROJECT NARRATIVE The Maine IDeA Network of Biomedical Research Excellence in comparative functional genomics will increase research capacity and competitiveness in Maine through programs and activities that foster research excellence and promote career and institutional development. Our Network establishes a critical mass of institutions that work collaboratively on biomedical research and training programs that provide a pipeline connecting a highly trained, skilled workforce to health science jobs and careers in Maine.